Using Rendever to improve the quality of life of older adults with cognitive impairments in senior living communities and their family members who live at a distance.

ABSTRACT
The United States is experiencing a public health crisis on a massive scale due to the number of
people with dementia, lack of cures, and challenges associated with caregiving for this population.1,2
until cures for the dementias are discovered, new technologies and interventions are imperative that
can reduce the stress and emotional burden of Alzheimer’s disease (AD) and Alzheimer’s
disease-related-dementias (ADRD) for older adults and their family members (NIA strategic plan).
Unfortunately, COVID-19 has exacerbated challenges related to social isolation and poor mental
health in senior living communities. The virtual reality (VR) program, Rendever, provides an
innovative and affordable solution to these challenges by enabling older adults in senior living
communities to maintain important family relationships, engage fully with life, and reconnect with
their past, regardless of physical location, through its advanced communication and network
capabilities. There is neurological, behavioral, and physiological evidence that virtual environments
allow people to feel the emotional presence of others in ways that surpass their location in space.3
Unfortunately, little research has examined its impact on older adults’ social relationships, primarily
due to a lack of networking and communication capabilities of other VR programs. Phase I tested the
feasibility of Rendever with residents with mild cognitive impairments (MCI) or mild to moderate
dementia and their family members who lived at a distance. Our results showed it to be safe, easy to
use, highly satisfying, and transformative for the 21 resident-family member dyads who used it.
Residents with MCI and dementia equally loved the VR, with residents with dementia reporting
greater immersion.This Phase II project expands our test of the live streaming and network features
of Rendever with 192 resident-adult child dyads across 12 senior living communities in Central
California and Boston with an experimental design. Our aims focus on the impact of Rendever on the
quality of life of residents and their adult children who live at a distance and whether this association
depends upon residents’ level of cognitive impairment. We also focus on the adult children and
whether participating inRendever with their parent reduces care-giver guilt. If Phase II is successful,
Rendever will be the only product that allows residents to still travel, view family photos and videos,
and go back in time to one’s childhood home and other memorable locations with one’s family in VR
and share stories while doing it, despite geographical separation and cognitive/physical challenges.
Importantly, Phase II will provide a rigorous, scientific test of whether Rendever can improve
residents’ and family members’ quality of life.

Public health relevance
NARRATIVE This Phase II STTR continues to refine and test the live streaming and networking capabilities of Rendever, which is a virtual reality (VR) platform designed to help older adults maintain important family relationships, engage fully with life, and reconnect with their past. Specifically, we examine the impact of Rendever on the quality of life of residents in senior living communities and their adult children who live at a distance, and determine whether this impact depends upon the residents’ level of cognitive impairment (i.e., mild cognitive impairment vs. mild to moderateAlzheimer’s disease and Alzheimer’s disease-related-dementia). The findings will validate the long-distance feature of Rendever by providing a rigorous, scientific test of it with 192resident-adult child dyads, with the ultimate goal of improving quality of life (e.g., reducing loneliness, improving mental health and thriving) and reducing caregiver guilt.